The Development of Gut Microbiota and Behavioral Inhibition in Childhood: The Role of Early Stress and Brain Development

Project Summary
Early toxic stress can lead to enduring long-term effects on neurodevelopment and behavioral
outcomes in children. One mechanism that may mediate these associations is the gut
microbiome. There is robust evidence that patterns of gut microbiota may influence
neurodevelopment and anxiety-related behaviors in rodents, but there is sparse literature on this
association in humans. Recent findings from our research team are the first to reveal that the
gut microbiome significantly predicts fear behavior in 1-year-old children. Thus, the proposed
study will examine the influence of psychosocial stress on the development of gut microbiota,
mediated by chronic HPA axis activation, as well as the bidirectional relationship between the
developing microbiome and behavioral inhibition across the first four years of life. We will
measure alterations in brain development across this time as a mediator of the relationship
between the microbiome and behavioral inhibition. During this sensitive period the microbiome
and brain are rapidly developing and may be most susceptible to environmental input.
Participants (n = 200) will be drawn from a prospective longitudinal cohort study funded by NICHD
(Brain and Early Experience Study (BEE); R01 HD091148-01A1). Assessments will be conducted
during lab visits at 36 and 54 months and home visits at 6 and 24 months of age. Psychosocial
stress will be assessed via observational assessments of negative parenting behavior and
household chaos at 6 and 24 months, and HPA axis activation will be measured via hair cortisol
at these visits. At all ages, fecal samples will be collected to assess microbial diversity and
maturity and behavioral inhibition will be assessed via maternal report and observational
measurement. Neuroimaging using high resolution magnetic resonance imaging, diffusion tensor
imaging, and resting state fMRI will provide measures of volumetric growth of the mPFC and
hippocampus from 15 months to 54 months, and structural and functional connectivity between
the amygdala and mPFC. Finally, at 54 mos a brief structured diagnostic interview for major
pediatric psychiatric disorders will be conducted (Mini International Neuropsychiatric Interview).
This study will be the first to investigate the influence of early psychosocial stress on the gut
microbiome, neurodevelopment and anxiety related behavior. Our long-term goal is to
determine how colonization of the gut microbiome impacts human brain development and later
risk for psychopathology in order to prevent the onset of psychiatric illness or reduce its
severity. Findings from this study, during a sensitive period of early childhood, will provide
important information that could inform intervention and prevention efforts soon after birth.

Public health relevance
Project Narrative Millions of children aged 3-17 year have diagnosed anxiety disorders and are at higher risk for poor performance in school, difficulties in social situations, and increased substance use. The proposed study aims to examine the influence of exposure to toxic stress across the first years of life on the gut microbiota, which has been found to alter neurodevelopment and subsequent behavioral inhibition, leading to anxiety symptoms in later childhood. Given limited public health resources, it is important to identify these specific targets for early intervention and thus the proposed research has strong potential for advancing the NIMH's mission of transforming the understanding and treatment of mental illnesses.